Tools to determine and analyze the structures of molecular machines in motion

PROJECT SUMMARY/ABSTRACT
Tools to determine and analyze the structures of molecular machines in motion
Single particle cryo-electron microscopy (cryo-EM) has transformed our ability to rapidly determine high
resolution structures of static, structurally homogeneous macromolecular complexes. However, we have not
realized cryo-EM’s potential to uncover the full ensemble of heterogeneous structures these molecules adopt as
they function. The overall objective of this work is to develop novel cryo-EM image processing tools to: 1)
determine the complete ensemble of structural states adopted by imaged complexes; 2) quantify the relative
abundance of these states; 3) monitor how the distribution of these states changes as the machine functions;
and 4) use this information to understand the molecular mechanism of how these machines assemble and
function. This objective is important as visualizing structural ensembles can be vital in developing and testing
hypotheses for how these machines function, and in developing therapeutics to modulate their activity. Here, we
specifically aim to develop two tools to facilitate achieving these overall objectives. First, we will generate
‘benchmark’ datasets that will be distributed to the methods development community to aid in building and
quantitatively assessing of the fidelity of different approaches to reconstruct 3D density maps from single particle
cryo-EM data. These benchmark datasets will include macromolecular complexes bearing elements of structural
heterogeneity we have specifically designed for this purpose, and that we have biochemically assembled and
imaged. Additionally, it will design, implement, and validate a machine learning-based computational tool that
more realistically simulates the imaging process than existent software, thereby enabling users to rapidly
construct custom synthetic benchmark datasets to test specific aspects of their own algorithms. Recently, as a
proof-of-concept, we published the first method using deep neural networks to perform 3D reconstruction from
single particle data, and this approach was particularly efficacious is revealing heterogeneous structures. Thus,
our second aim is to develop this approach into a complete software package enabling users to readily
reconstruct hundreds-to-thousands of density maps from a single dataset; to implement tools to focus the
analysis on specific structural regions; and to deploy methods guiding the interpretation of the density maps and
the construction of ensembles of associated atomic models. This work in innovative in its objective to analyze
heterogeneous structural ensembles as opposed to static structures at high resolution; in our approach to model
model conformational changes as originating from a continuous distribution of structures as opposed to isolated,
discrete states; and in our application of deep learning methods to both the generation of benchmark datasets
and in the reconstruction process itself. As a proof-of-concept, our reconstruction approach has proven
significant as evidenced by its recent application in multiple structural studies, and we expect the tools we
propose to develop here will be broadly impactful on a wide-array of NIH-funded research programs that rely on
single particle cryo-EM.

Public health relevance
PROJECT NARRATIVE The conformation and composition of massive molecular machines change as they are assembled and as they perform their essential cellular functions. Work proposed here will produce broadly impactful computational tools to determine the structures of these dynamic machines in motion. Such structures are critical in furthering our understanding of how these molecules function in healthy cells and how they fail in times of disease, and in guiding the development of therapeutics treating a wide array of human illnesses.